Vitamin A Status and its Relationship to S. mansoni Infection Intensity and Environmental Enteric Dysfunction in Preschool-Aged Children Receiving Treatment for Schistosomiasis in Uganda

PROJECT SUMMARY/ABSTRACT
The overall goals of this proposal are to advance our understanding of the role of vitamin A deficiency in the
pathogenesis of schistosomiasis and environmental enteric dysfunction (EED) and to advance the career
development of the candidate. Understanding the mechanistic role of vitamin A deficiency in the pathogenesis
of intestinal schistosomiasis will offer opportunities for nutrition-based interventions to reduce infection-related
morbidity. In low- and middle-income countries (LMICs), the overlapping burdens of undernutrition and
infection have significant health consequences for infants and children, including impaired linear growth and
stunting. Stunting affects a third of children living in LMICs and can lead to life-long impact on educational
outcomes, economic productivity, and birth outcomes for women. Vitamin A deficiency, intestinal
schistosomiasis, and EED all contribute to childhood undernutrition and stunting and likely share common
mechanisms through intestinal barrier dysfunction with concomitant activation of systemic immune responses.
Studies from both animal models and humans provide scientific premise for the role of these insults in impaired
linear growth. A recently developed inflammation-adjustment strategy allows for the determination of vitamin A
status among individuals with infection or inflammation, but no studies have examined adjusted vitamin A
status in the context of human schistosomiasis or EED. The proposed research will leverage the well-
characterized samples and clinical data from an ongoing NIH-funded randomized, controlled phase II trial (R01
HD095562) of praziquantel (PZQ) treatment in N = 300 children under age four with Schistosoma mansoni
infection in the Lake Albert region of Uganda. The parent trial hypothesizes that key morbidities related to
schistosomiasis (undernutrition, anemia of inflammation, and linear growth stunting) are in part driven by EED
with consequent malabsorption and systemic immune activation. The proposed research will add
measurements of vitamin A in samples collected from the parent trial to examine mechanisms through which
inflammation-adjusted vitamin A deficiency contributes to EED and schistosomiasis-related morbidity. The
proposed research will 1) examine the relationships between adjusted vitamin A status and S. mansoni
infection intensity and immunologic response markers collected at the baseline visit and 2) assess the
relationships between vitamin A status and EED biomarkers both at baseline and longitudinally in response to
PZQ treatment. This work will address innovative hypotheses regarding the role of vitamin A status in the
pathophysiology of EED in the context of S. mansoni infection and its impact on treatment efficacy. Further, the
proposed training plan will advance the career development of the candidate with respect to a) building subject
matter expertise in the immunopathogenesis of schistosomiasis and EED, b) gaining research experience in
the implementation of randomized controlled trials in vulnerable populations under a sponsor’s supervision,
and c) expanding methodological capabilities to include longitudinal data analysis.

Public health relevance
PROJECT NARRATIVE In low- and middle-income countries, infants and children face overlapping threats from undernutrition and infection, particularly neglected tropical diseases, which increase their risk for severe illness and death. The proposed research will leverage the participant samples and data from an ongoing clinical trial to investigate the mechanistic role of vitamin A deficiency on immune function and gut health among children in Uganda infected with intestinal schistosomiasis, a chronic parasitic disease. Understanding the role that vitamin A status plays in the context of schistosomiasis will advance scientific knowledge and will offer opportunities for nutrition-based interventions to improve the long-term health of children living in areas with overlapping burdens of vitamin A deficiency and schistosomiasis.